Quality Improvement in time to Treatment of Status Epilepticus (QuITT-SE)

Acute seizures may evolve into status epilepticus (SE), i.e., prolonged or repeated seizures without
regaining consciousness, resulting in irreversible brain injury or death costing ~$4 billion annually to the US
healthcare system. If seizures are treated rapidly with a correctly-dosed benzodiazepine (BZD), SE and its
associated morbidity and mortality may be averted. For instance, children treated after 10 minutes of seizure
onset are 11 times more likely to die during their hospitalization than patients treated earlier. Therefore, the
American Academy of Neurology identified time to treatment as a quality metric to evaluate SE care. Despite
these evidence-based recommendations, delayed seizure treatment remains the status quo in many centers.
The Quality Improvement in Time to Treatment of Status Epilepticus (QuITT-SE) study will examine the
implementation and effects of a standardized set of QI interventions across pediatric hospitals with diversity in
geography, patient demographics and resources. The proposed interventions were developed and tested in a
single-center study that doubled the number of SE episodes treated within guideline timing, decreased morbidity,
and mitigated over $2 million of charges in the following 17-month period. Our overarching goal is to study the
implementation of these QI interventions and their effect on time to SE treatment across multiple centers utilizing
an effectiveness-implementation hybrid design. The QuITT-SE trial will be a stepped-wedge cluster randomized
trial across multiple sites within the Pediatric Status Epilepticus Research Group, an established consortium of
hospitals with expertise in studying and treating SE in children. During this project, mixed qualitative and
quantitative methods will be used to identify implementation factors related to the interventions. In addition, the
use of standardized QI processes within the Practical, Robust Implementation and Sustainability Model (PRISM)
will facilitate the identification of site-specific drivers and themes pertaining to delayed SE treatment, improving
the generalizability of findings.
The specific aims are: 1) Primary: Determine how implementing a QI bundle impacts the time to treat
SE among hospitalized, non-critically ill children. 2a) Secondary: Determine the effect on Pediatric Cerebral
Performance Category score among hospitalized, non-critically ill children after implementing a QI bundle. 2b)
Secondary: Determine the effect of dissemination of a QI bundle on cost of hospitalization for SE among
hospitalized, non-critically ill children 3) Exploratory: Explore the factors implicated in implementing a QI bundle
on the time to treat SE among hospitalized children.
Public Health Impact: Each year, SE results in an estimated 15,000-45,000 deaths in children in the US
and costs ~$4 billion, increasing markedly with more prolonged seizures. Successful completion of QuITT-SE
will produce a set of evidence-based interventions alongside an implementation framework to improve outcomes
and value of SE treatment across diverse hospital settings.

Public health relevance
PROJECT NARRATIVE Acute seizures may evolve into status epilepticus (SE) which can result in irreversible brain injury or death and costs ~$4 billion per year to the US healthcare system. The QuITT-SE effectiveness-implementation hybrid trial utilizes quality improvement interventions and methods derived from a single-center project that improved outcomes in children and mitigated over $2 million in charges. By studying the effects of these interventions and their implementation across an established research consortium, we will develop and refine a standardized toolkit and implementation framework to improve the safety and value of SE treatment across diverse hospital settings.